Mechanisms for generating cargo specificity in inflammasome-mediated exosome secretion

PROJECT SUMMARY
Exosomes mediate intercellular communication and their roles in a growing range of human
disease is becoming increasingly evident. In preliminary studies, our lab has discovered that both virus-
and LPS-induced exosome production is related to inflammasome activation resulting in cleavage of
the Rab7 effector protein, RILP. The loss of RILP from the Rab7 complex reroutes intracellular
trafficking toward the cell surface. This results in enhanced exosome secretion, due in part to a
redistribution of multivesicular bodies throughout the cellular periphery. Formation of the cleaved form
of RILP (cRILP) can also induce unique exosomal cargo loading, leading to the selective enrichment
of specific pro-inflammatory miRNAs. Furthermore, inhibiting RILP cleavage can abrogate the
proinflammatory actions generated by cRILP while specifically facilitating an anti-inflammatory
response. This proposal will examine the hypothesis that enhanced exosome production that
results from inflammatory disease is a consequence of inflammasome-triggered casepase-1
activation and subsequent cleavage of the trafficking adapter protein RILP. Cleaved RILP
subsequently reprograms secretory events promoting stimuli-specific exosome formation and
release.
We will investigate this hypothesis with the following specific aims: Aim 1 will identify the
mechanism by which cRILP regulates selective miRNA cargo loading. We hypothesize that the
various forms of RILP may interact with and/or complex with specific subsets of RNA binding proteins
that regulate miRNA cargo loading. Aim 2 will define the relationship between cRILP, RNABPs,
and components of the ESCRT pathway. This aim will explore the hypothesis that cRILP hijacks the
machinery required for exosome biogenesis leading to altered multivesicular body trafficking and
subsequent exosome release. Aim 3 will examine the functional consequences of RILP
manipulation on exosome secretion. This aim will identify how RILP manipulation, in both human
monocytes and mouse models, can affect the outcome of various disease states to ultimately lead to
the artificial modulation of exosome production and thus, the immune response.
The ultimate goal of this research is to provide a detailed understanding of how exosomes are
produced/secreted in response to pathogenic stimuli but also to describe the mechanisms that
inflammatory stimuli use to specifically induce selective exosome cargo secretion. This knowledge can
then be used to provide the tools to manipulate exosomes for therapeutic benefits.

Public health relevance
PROJECT NARRATIVE The phenomenon of increased exosome secretion in pathological states is well documented but as of yet, no mechanism has been proposed for how this occurs. In this study, we define a novel connection between the cleavage of the Rab7 effector protein, RILP and exosome secretion. We suggest that inflammasome-mediated RILP cleavage plays a significant role in altered intracellular trafficking, exosome cargo loading, and enhanced exosome secretion.